Fatty acid oxidation in female cardioprotection

ABSTRACT
Pre-menopausal women display a significantly lower incidence of cardiovascular disease than age-matched
men. However, the incidence of female cardiovascular disease increases markedly after the onset of
menopause, resulting in a relative loss of protection from heart disease. Decreased levels of estrogen are
closely linked to the loss of cardioprotection after menopause, but the biological mechanisms underlying this
connection are incompletely understood. While we know that estrogen signaling mediates the response to
various pathophysiological stimuli, we do not fully understand how estrogen regulates key metabolic pathways
in the failing heart. In the current proposal, we seek to understand whether relative reductions in cardiac fatty
acid oxidation underpin the loss of cardioprotection in post-menopausal female hearts. In Specific Aim 1, we
will determine how estrogen controls the abundance of GCN5L1, an enzyme that regulates cardiac fatty acid
oxidation. In Specific Aim 2, we will determine how GCN5L1 regulates cardiac fatty acid oxidation in mouse
models of female menopause. In Specific Aim 3, we will determine the requirement for fatty acid oxidation in
female cardioprotection.

Public health relevance
PROJECT NARRATIVE Pre-menopausal women display a significantly lower incidence of cardiovascular disease than age-matched men, however this relative protection is lost after menopause. While reduced estrogen levels in post- menopausal women have been linked to this loss of protection, the biological mechanism is not fully understood. In this proposal, we seek to understand whether changes in cardiac metabolism, caused by reduced estrogen levels, make the hearts of post-menopausal women more susceptible to injury and disease.